Impact of Obstructive Sleep Apnea and HIV on Ventricular Repolarization Lability

ABSTRACT
In the era of successful combination antiretroviral therapy, human immunodeficiency virus (HIV) infection has
shifted from a rapidly deteriorating disease to a manageable chronic condition with life expectancy similar to that
of individuals without HIV. However, the prolonged lifespan has brought about an increase in comorbidities such
as chronic obstructive pulmonary disease, type 2 diabetes, cardiovascular disease, and sudden cardiac death
(SCD). Sleep disorders, particularly obstructive sleep apnea (OSA), are prevalent among those living with HIV,
with recent data indicating a 47% higher prevalence in men with HIV compared to those without. OSA,
characterized by upper airway collapse during sleep, is known to independently increase the risk of hypertension,
cardiovascular disease, and cardiac arrhythmias, including SCD. Ventricular repolarization, a crucial aspect of
cardiac electrophysiology, is destabilized by OSA-induced sympathetic nervous system activation, potentially
leading to life-threatening arrhythmias. The QT variability index (QTVI), reflecting beat-to-beat QT interval
fluctuations derived from the surface electrocardiogram (ECG), is a predictor of ventricular arrhythmias and SCD.
Our preliminary data suggest that prevalent OSA is associated with increased ventricular repolarization lability
(increased QTVI), and incident OSA exacerbates this lability. Given our previous findings from the Multicenter
AIDS Cohort Study (MACS) of an increased QTVI in men with than without HIV, we aim to investigate the
interaction between OSA and HIV on ventricular repolarization abnormalities. Our overarching goal is to
delineate the independent and interactive effects of OSA and HIV on QTVI during sleep in a cohort of 851 men
living with and without HIV. We hypothesize that OSA severity, measured by the apnea-hypopnea index (AHI),
degree of nocturnal hypoxemia, and frequency of arousals, will be independently associated with higher QTVI.
Furthermore, men with HIV are expected to exhibit higher QTVI than those without HIV, with OSA exacerbating
the HIV-related increase in QTVI. Utilizing polysomnographic and ECG data from the MACS, we will employ
multivariable regression models adjusted for relevant covariates to explore these associations. Anticipated
results include independent associations between OSA severity, measures of hypoxemia and arousal frequency,
and ventricular repolarization lability, along with a heightened repolarization lability in men with HIV. We expect
OSA to augment the effects of HIV on repolarization lability, potentially increasing SCD risk. Given that OSA is
pervasive in the HIV population, findings from the proposed analyses will have a fundamental impact on clinical
practice by: (a) providing much-needed information on the pathogenesis of SCD risk in HIV, and (b) promoting
early identification and treatment of OSA in those with HIV.

Public health relevance
NARRATIVE Once regarded as a life-threatening condition, Human Immunodeficiency Virus (HIV) infection has transformed into a manageable chronic illness. Recent studies have demonstrated a higher prevalence of obstructive sleep apnea (OSA) among men living with than without HIV. Epidemiological evidence has also shown that OSA increases the risk of cardiac complications, such as sudden cardiac death (SCD). The increased risk of SCD in OSA may be attributed to its impact on ventricular repolarization abnormalities. This study aims to utilize polysomnographic data from the Multicenter AIDS Cohort Study, a longitudinal investigation of HIV, to determine the independent and interactive effects of OSA and HIV on ventricular repolarization lability.